Targeted Radionuclide Therapy to Enhance the Efficacy of CAR T Cells Against Neuroblastoma

PROJECT SUMMARY/ABSTRACT
Quaovi Sodji, MD, PhD is a Tenure track Assistant Professor in the Department of Human Oncology at the
University of Wisconsin School of Medicine and Public Health in Madison. His long-term goal is to use his
acquired clinical and research expertise in radiation oncology, drug discovery and cancer immunotherapy to
develop treatments that can improve the lives of patients with solid tumors including the pediatric cancer
neuroblastoma. He aims to develop a translational research program investigating the use of low-dose targeted
radionuclide therapy (TRT) to sensitize tumors to killing by chimeric antigen receptor (CAR) T cells.
The purpose of this career development award is to provide Dr. Sodji with the support and mentorship needed
to develop a successful translational research program. His proposal will be performed under the primary
mentorship of Zachary Morris, MD, PhD, an expert in immuno-radiobiology and Christian Capitini, MD, an expert
in CAR T cell therapy. Other members of his mentorship committee include Paul Sondel, MD, PhD, an expert in
immunogenetics, Jamey Weichert, PhD, an expert in radionuclide chemistry and Bryan Bednarz PhD, an expert
in nuclear medicine. The training plan includes formal coursework, seminars, national conferences, and hands-
on training activities to expand expertise in 1) tumor immunology and CAR T cell engineering, 2) radiochemistry
and dosimetry, and 3) laboratory management, mentoring, and grantsmanship.
CAR T cells are “living drugs”, tailored to each patient that can directly recognize and kill cancer cells. They
have been very effective against blood cancers, but not against solid tumors including one of the most common
childhood cancers, neuroblastoma, which is very deadly cancer when it relapses. This limitation of CAR T cells
in solid tumors has been attributed to their inability to penetrate the tumors and the loss of their killing potential
over time. TRT, a form of radiation where a radioactive chemical is linked to a drug that can selectively deliver it
to cancer cells, has been shown to increase the infiltration of immune cells into tumors and the susceptibility of
tumor cells to immune-mediated destruction. The goal of this proposal is to use TRT to deliver radiation to all
tumors throughout the body to overcome the factors that presently limit the success of CAR T cells against solid
tumors like neuroblastoma. This proposal aims to 1) identify the amount of TRT-emitted radiation that CAR T
cells can safely withstand, 2) determine if and how this form of radiation increases the potential of CAR T cells
to kill tumor cells and 3) evaluate whether TRT in combination with CAR T cells is effective in eradicating tumors
in murine models of neuroblastoma. This proposal will lay the groundwork to justify the evaluation of this
combination therapy in clinical trials for patients with neuroblastoma. Our anticipated findings will have enormous
translational potential as a therapeutic approach that could be tested in any cancer for which a tumor-selective
TRT agent and a tumor surface antigen-specific CAR T cell could be engineered.

Public health relevance
Project Narrative Despite revolutionizing the treatment of hematological malignancies, chimeric antigen receptor (CAR) T cell therapy has had limited efficacy against solid tumors including pediatric neuroblastoma, which is associated with a dismal prognosis upon recurrence. To overcome the molecular and cellular mechanisms that limit the efficacy of CAR T cells against neuroblastoma, we will use targeted radionuclide therapies that selectively deliver low dose radiation to all tumors throughout a patient’s body to stimulate infiltration and activation of CAR T cells in these sites. We expect that this project will provide the preclinical data needed to justify clinical studies that will test the safety and efficacy of combining for the first-time targeted radionuclide therapy and CAR T cells for treatment of children with neuroblastoma and potentially any type of cancer.